FURTHER EXAMINATION OF ELEVATIONS IN PAIN THRESHOLDS IN BULIMIA NERVOSA

Our research is directed toward further characterization of our finding of elevated pain thresholds in bulimia nervosa subjects. We have collected data on changes in pain thresholds in women during a binge/purge episode. We plan to pursue studies to detail the pharmacological basis of the elevations in pain thresholds in the near future.